Regulation of GluN2B-NMDA Receptors by Interactions with the Actin Cytoskeleton

Project Summary
N-methyl-D-aspartate receptors (NMDARs) are glutamate-gated ion channels composed of transmembrane
GluN1, GluN2 (A-D), and GluN3 (A-B) subunits that mediate Ca2+ influx into the dendritic spine. Importantly, the
unique intracellular tail of the GluN2B subunit is essential for learning and memory. Furthermore, autism
spectrum disorder (ASD) and schizophrenia (SCZ) associated variants are found within the GluN2B intracellular
tail. My overall goal is to elucidate a novel mechanism by which GluN2B tails contribute to the function of GluN2B-
containing NMDARs (GluN2B-NMDARs). Previous experiments showed that actin-targeting drugs impact
NMDAR activity, but the underlying mechanisms are unknown. My preliminary data strongly support the
primary hypothesis of this project: a direct interaction between actin filaments and the GluN2B
intracellular tail regulates NMDAR activity. The objective of my proposed project is to elucidate the
biochemical basis for an interaction between the GluN2B tail and actin filaments and determining how this
interaction regulates NMDAR function. I will achieve this objective by pursuing three highly complementary aims:
Aim 1. Define the minimal fragment of GluN2B intracellular tail that mediates high affinity binding to actin
filaments and the interfaces on GluN2B and actin that mediate binding. My preliminary data show a direct
interaction between GluN2B tails and actin, but the key interfaces that mediate this interaction between the
proteins is unknown. I will use recombinant proteins to perform quantitative binding assays and cross-linking
assays to identify the minimal fragment of the GluN2B tail needed to mediate a high affinity interaction with actin.
Aim 2. Characterize how Ca2+ and genetic variants impact GluN2B:actin binding. Ca2+ decreases NMDAR
activity in cultured hippocampal neurons, but whether Ca2+ selectively impacts GluN2B-NMDAR activity is
unknown. My preliminary data suggest Ca2+ strengthens the GluN2B tail:actin interaction. Genetic variants that
lie within GluN2B tail regions that I found bind actin have been identified in patients with ASD and SCZ. Clusters
of conserved and positively charged residues can contribute to actin binding of proteins. I will perform quantitative
binding assays to identify how Ca2+ levels, disease-associated variants, and clusters of conserved and positive
residues impact the GluN2B tail:actin interaction.
Aim 3: Determine how manipulations of the actin cytoskeleton and GluN2B tail impact GluN2B-NMDAR
activity. Changes in actin polymer state impact NMDAR activity in neurons. However, whether actin selectively
impacts GluN2B-NMDARs or is mediated by GluN2B tail:actin interactions is unclear. I will monitor changes in
GluN2B-NMDAR mediated currents in HEK293 cells to determine the impact of 1) actin-targeting drugs and 2)
disrupting the GluN2B tail:actin interaction. After mastering these techniques, I will monitor how actin dynamics
and GluN2B tail:actin interactions impact NMDAR activity in cultured hippocampal neurons.

Public health relevance
Project Narrative Genetic variants in NMDA receptor subunits, including variants within the intracellular tail of the GluN2B subunit greatly increase risk for schizophrenia, autism, and related neurodevelopmental disorders, but how they impact NMDAR function is unclear. My proposed studies will elucidate a novel mechanism by which GluN2B intracellular tails regulate NMDAR function. These studies could reveal whether distinct functions of NMDAR subunits could serve as a potential target for therapeutic interventions to treat NMDAR-associated disorders.